Admin-Core

A Program Project of the complexity as the one introduced in this application requires an Administrative Core
(Core A) Co-Led by Drs. Dixit and Scherer. An important goal of Core A is to promote the intellectual
relationship between all projects as the studies begin to yield data. Responsibilities include the facilitating the
communication among all projects and cores, data analyses, statistics, financial management and
administrative services needed on a day-to-day basis for all program participants. Key functions are also to
establish program priorities, optimize the sharing of resources among Projects and Cores, generate routine
reports to assess progress with respect to stated goals, communicate scientific advances and progress at
monthly investigator meetings, promote scientific relationships and communicate with the members of the
Scientific Advisory Committee. The Administrative Core will be headed by Dr. Dixit, who is a NIA funded
investigator and brings many years of experience at managing P01 and multiple NIH R01 awards. Since his
research training at NIA-Intramural Program, he has pursued studies in transgenic mouse models as well as
humans to investigate the role of immune-metabolic interactions that control age-related inflammation and
immune-senescence. Core A will be supervised by the Executive Committee. The PPG will have scientific
input from both an Internal (Drs. Iwasaki, Bennet, Elmquist and External Advisory Committee whose
communication will be handled through the Administrative Core. Dr. Dixit and Scherer will also organize
regular meetings among the PPG participants to assure that projects are well coordinated. Aim 1:
Communication and manage the PPG and its relationships within the Yale and UT Southwestern communities.
Aim 2: Manage the PPG relationships external to Yale and UTSW. Aim 3: Data interpretation and consultations
with scientific advisory board for development of plans for future studies.